Elucidating structural, mechanistic, and allosteric determinants of mTOR Complex 2 (mTORC2) signaling.

Taylor, Martin | K08 (PA-20-203) | PROJECT SUMMARY / ABSTRACT
This proposal details a five-year training plan for the development of a research program focused on elucidating
structural, mechanistic, and allosteric determinants of mTOR Complex 2 (mTORC2) signaling. Phosphorylation
of the signaling kinase Akt on Ser473 by mTOR Complex 2 (mTORC2) is a critical regulated intracellular step in
insulin and other growth factor signaling. Ser473 phosphorylation activates Akt and is required for Akt’s
downstream metabolic effects, such as glucose transporter upregulation, which are dysregulated in diabetes,
and proliferation and growth, which are dysregulated in cancer. Therapeutic modulation of mTORC2 is therefore
of interest in the treatment of both diabetes and cancer but is not yet possible due to similarities between
mTORC2 and the better-understood effector complex mTORC1, which shares key components mTOR and
mLST8. mTORC2 also activates other substrates with less-defined roles in ion channel homeostasis, apoptosis,
cell motility, metastasis, and insulin receptor sensitivity, and its activity is modulated by a series of allosteric
interacting proteins including the small GTPases Rho and Ras. However, despite the central role of mTORC2-
Akt signaling, we have little information about how this critical reaction is catalyzed by mTORC2, how mTORC2
recognizes Akt and other substrates, or how these interactions are modulated allosterically. This project therefore
seeks to develop a detailed structural and mechanistic understanding of mTORC2 recognition of its substrates,
using novel enzymologic assays, protein engineering, and a combination of biochemical, chemical, proteomic,
and structural biology approaches that will also develop proof-of-concept inhibitors and potentially activators of
mTORC2.
My proposed studies will:
(i) provide detailed structural and mechanistic insight into mTOR Complex 2 kinase signaling
(ii) develop tools, reagents, and techniques applicable to other systems of interest, including mTORC1
(iii) provide ample opportunities for mechanistic and translational follow-up for my transition to independence.
I am a practicing gastrointestinal pathologist and physician scientist seeking K08 support for mentored research
under the guidance of Dr. David Sabatini and Dr. Philip Cole. This mentored period of 80% research and career
development and 20% clinical time will ensure I acquire the skills required to become a successful independent
principal investigator. Drs. Sabatini and Cole are internationally recognized mentors, together training ~40
successful independent investigators. My training will occur at two world-class institutions, the Whitehead
Institute for Biomedical Research, and Massachusetts General Hospital Department of Pathology. Both are rich
with opportunities for young scientists to train, pursue highly impactful science, and foster long-lasting
collaborations. I will also be guided by a committee of researchers that are all leaders in their fields: Dr. Joseph
Davis (MIT, structural biology of large protein complexes and cryoEM data analysis) and Dr. Yi Shi (University
of Pittsburgh, crosslinking mass spectrometry as applied to large protein complexes and nanobody generation).
The support of this K08 award will allow me to focus on maturing my research and strengthening my career
development during this critical last stage of mentored training. At the conclusion of my award period, I will be
optimally positioned for achieving success as an independent physician scientist.

Public health relevance
Taylor, Martin | K08 (PA-20-203) | PROJECT NARRATIVE Selective therapeutic modulation of the two mTOR effector complexes, mTORC1 and mTORC2, is a key goal for the treatment of diabetes and many types of cancers because dysregulation of these signaling complexes play central and often opposing roles in disease pathophysiology, but we lack the detailed structural and mechanistic information about both complexes that would enable development of these therapies. For example, in type 2 diabetes, overfeeding results in hyperstimulation of mTORC1, which measures nutrients, resulting in inhibition of mTORC2, which then fails to transmit the critical insulin signal and leads to insulin resistance; in this context, it would be advantageous to selectively inhibit mTORC1, preventing this feedback loop, or selectively activate mTORC2, mitigating insulin resistance. The overarching goal of the scientific arm of this project is to learn about the structure and mechanism of mTORC2 in detail so that we could develop these selective strategies for better treatment of diabetes and cancer.